Second and Third Waves of the Mexican Family Life Survey

DESCRIPTION (provided by applicant): MxFLS-1 is a broad-purpose, multi-topic, nationally representative survey of individuals, households and communities collected in 2002. The survey covers over 8,400 households in 150 communities across the whole of Mexico. The principle goal of this project is to field and place in the public domain two follow-up waves of the Mexican Family Life Survey. These data, in combination with the first wave of the survey, will yield a uniquely rich longitudinal database for better understanding the social, economic, demographic and health changes occurring in Mexico during the first decade of the 21st century. Integrating changes at the community level with household-level information, it will be possible to monitor the impact of social and economic changes as well as measure the effect of social programs on the well-being of the population. MxFLS-2 and -3 will follow the substantive content of MxFLS-1, but will also include new, innovative modules in order to provide the highest quality multi-purpose survey for scientific research on the dynamics of behavioral change over the life course. New modules will elicit information about preferences and expectations, about non co-resident family members, and about cognitive achievement and will include new biomarkers. A second aim of this project is to provide scientifically sound evidence regarding the effects of migration to the United States on those who move and on those who stay in Mexico. Specifically, we will follow the respondents from the baseline who have moved from Mexico and interview them in the United States. Public use files will be placed in the public domain within 12 months of completion of fieldwork.